Administrative Core

An Administrative Core is required to perform the operations necessary to the smooth and efficient operation of the Program. The Administrative Core will be responsible for the personnel administration of each of the projects and cores. On a daily basis the Administrative Core will order supplies, equipments, and services necessary to the operation of projects and cores. The Administrative Core will also be responsible for recording expenses associated with these functions, and will perform bookkeeping tasks necessary to reconcile the Program Projects accounts with the University ledgers. The Administrative Core will also be responsible for the organization and execution of the annual retreat that will include the External Advisory Committee meeting. In addition, the Administrative Core will maintain close communications with each of the project investigators and core directors, as well as their secretarial and administrative staff.